NORMAL BLOOD COLLECTION FOR BIOMEDICAL RESEARCH AT SCRIPPS CLINIC

Facilities are provided for the drawing of blood by the Core Lab phlebotomy personnel from normal volunteers who are Hepatitis B, Hepatitis C and HIV free on initial and annual screen, and have normal blood counts. Blood is used for a variety of IRB-approved research projects. Records of donor and investigator activity are maintained by the Core Laboratory staff.